PHYSIOLOGICAL STUDIES OF THE PRIMATE VISUAL SYSTEM

This project involves study of the physiological organization of neurons of the visual system of primates, with emphasis on the chromatic properties of color-opponent ganglion cells and of cells from the lateral geniculate nucleus and the primary visual cortex of macaques.